Anatomical and functional organization of inter-areal feedback circuits in the visual cortex, and their impact on neuronal responses

In the mammalian sensory cortex, hierarchically-organized areas are reciprocally connected via feedforward (FF)
and feedback (FB) circuits. FF connections generate the more complex response properties of neurons in higher
areas within parallel streams specialized in processing specific stimulus attributes. In contrast, the function of
FB connections remains unknown. In the visual cortex, FB has been implicated in top-down phenomena, such
as visual attention, prediction, and visual context. However, these roles have remained hypothetical, due to the
lack of tools to selectively label, record, and manipulate the activity of FB neurons. As FB circuits are ubiquitous
in cortex, and abnormalities in FB connectivity and function in humans have been linked to neurological
disorders, such as attention deficits and autism, it is important to understand normal FB connectivity and
function in primates. During prior funding, we developed novel viral and optogenetic tools to selectively label FB
neurons, trace their inputs and outputs, and record and manipulate their activity in primate cortex. Using these
tools, we found that, anatomically, FB connections between visual areas V2 and V1 form parallel pathways, make
direct contacts with V1 neurons sending FF projections to V2, and link V2 and V1 neurons preferring similar
visual stimulus features. Functionally, we found V2 FB conveys global visuo-spatial information to V1, and
controls the receptive field size, surround suppression and response amplitude of V1 cells. In these studies,
however, we did not disentangle FB connections related to different layers. Anatomical, functional and
theoretical evidence indicates that within each parallel FB pathway there are at least two, and probably more,
sets of FB arising from, and terminating in, different layers, likely having distinct organizations and functions.
Our goal is to understand the connectivity and computational function of FB connections related to different
layers of origin and termination within each FB stream. Using selective labeling of FB neurons, we will
determine the differential contribution of FB from different V2 layers to their V1 termination layers. Moreover,
using rabies-virus-mediated monosynaptic input tracing (TRIO) combined with optical imaging of V1 and V2
functional maps, we will determine the functional connectivity of, and the V1 cell types targeted by, different
laminar-specific FB sets (Aims1,2). Finally, we will optogenetically manipulate the activity of distinct V2 FB sets
to determine their differential impact on V1 neurons' spontaneous and visually-evoked responses (Aim3).
Impact. This proposal will reveal the anatomy and function of laminar-specific FB circuits between V2 and V1.
This information will inform and refine models of FB function, influence the design of artificial systems striving
to achieve vision, and provide new insights into the circuit-level bases for neurological disorders that have been
linked to abnormal FB connectivity and function (attention disorders, autism).

Public health relevance
NARRATIVE Normal brain function depends on the orderly development of circuits in the cerebral cortex and on their intact function. Knowledge of the normal circuitry provides a foundation for understanding the causes of impaired brain function and developing corrective measures. Our studies of the normal circuitry between early visual cortical areas will provide greater insight into the causes and effects of central vision defects when these circuits are damaged by stroke or other neurological or developmental cause. In particular, our studies of feedback circuits between different visual cortical areas will help our understanding of how these pathways mediate the influence of stimulus context on neuronal responsivity, spatial integration, and changes in visual sensitivity associated with top-down attention. Moreover, understanding how these circuits operate in normal vision will provide a foundation for understanding the consequences of their dysfunction in neurological and psychiatric disorders, such as autism, schizophrenia and attention deficits disorders, which have been directly linked to abnormalities in inter-areal connectivity [e.g. Belmonte et al. J. Neurosci. (2004) 24:9228-9231; Lynall et al. J. Neurosci. (2010) 30:9477-9487].